Development of diagnostic and prognostic tests for esophageal adenocarcinoma

Abstract. The primary goal of this proposal is to develop novel molecular approaches for early detection of
esophageal adenocarcinoma (EAC). EAC arises in the setting of gastroesophageal reflux disease (GERD) and
Barrett's esophagus (BE); a metaplastic change resulting from GERD. This knowledge has driven endoscopic
screening and surveillance recommendations for individuals with GERD and BE but compliance is low and the
vast majority of new EAC cases are still diagnosed at late stage, when the tumor is inoperable and prognosis is
extremely poor. Over the past 6-8 years, we have developed a highly collaborative, multi-institutional and multi-
disciplinary team focused on the development of clinically useful biomarkers for EAC. This proposal will build
on our previously funded projects and the clinical and technical resources available to us through these
studies, in order to evaluate two different approaches to early detection of EAC. The first approach is based on
detection of somatic mutation and DNA copy number abnormality signatures in esophageal cytology samples.
Published studies and our own ongoing work strongly indicate that accumulation of somatic mutations and
major chromosomal rearrangements drive the progression from BE to EAC. We believe that these changes
can be leveraged to identify a genomic signature for progression that can be detected in cytology samples
using a targeted next-generation sequencing (NGS) test. Identification of the genomic signature is ongoing in
our group through large-scale comparative sequencing of EAC and pre-neoplastic tissue samples. To evaluate
the effectiveness of this signature in identifying progression, we are currently collecting ~350 esophageal
cytology samples using an encapsulated sponge called the EsophaCap™. This device is not yet commercially
available, but has been provided to us under arrangement with CapNostics LLC and is currently approved for
investigational testing in the USA and Canada. These unique data and tissue resources will be used in Specific
Aim 1 to evaluate the sensitivity and specificity of a targeted NGS analysis of esophageal cytology samples to
detect dysplasia and early EAC. The second approach also leverages our large-scale sequencing data and
targeted sequencing assays, but in this case we will evaluate the detection of mutations in circulating, cell-free
DNA isolated from plasma as a biomarker for EAC. We are currently collecting plasma from all patients who
swallow the EsophaCap™ device and this provides an excellent tissue resource in which to test detection of
circulating tumor DNA (ctDNA). To aid in the detection of ctDNA, we have developed an ultra-sensitive NGS-
based assay that can detect mutations at multiple loci with sensitivity as low as 0.05% (1/2000) mutant allele
fraction. These resources will be used in Specific Aim 2 in order to evaluate the sensitivity and specificity of
ctDNA for detection of stage I and II EAC. Finally, studies indicate that ctDNA detection may have prognostic
value. In Specific Aim 3 we will evaluate the prognostic value of ctDNA in stage I and II EAC patients with the
hope that this may prove useful for directing neoadjuvant therapy in these patients.

Public health relevance
Narrative. Esophageal adenocarcinoma is a deadly disease with rapidly increasing incidence. Five-year survival rates are approximately 15% and much of this can be attributed to the fact that the majority of tumors are diagnosed at late stage. In this proposal we will evaluate two different approaches to early detection of esophageal adenocarcinoma using genetic and genomic changes as a biomarker for disease. If successful, this could lead to alternative paradigms for early detection of esophageal adenocarcinoma and substantial improvements in patient outcomes.